MRI brain morphometry for computer-aided detection of neurological disorders

? DESCRIPTION (provided by applicant): The technology that is routinely available to neuroradiologists is years or decades behind that which is used in imaging research throughout the world. Current clinical decision-making in neuroradiology is based on information that is insufficient for detecting the subtle changes that presage clinically significant conditions such a a growing tumor, enlarging ventricle, or shrinking hippocampus. Tools that are regularly used in research are not accessible in the clinic due to a number of factors: slow execution speed, sensitivity to scanner manufacturer, field strength and pulse sequence, and lack of FDA clearance. In this project we seek to remove these barriers by further developing FreeSurfer, the world's premier automated brain morphometry package, to (1) integrate novel deep-learning and Random Forest- based patch-matching image synthesis technology into FreeSurfer to make it robust to variations in scanner platform and acquisition parameters, (2) use modern parallel-processing to reduce execution time to a clinically-feasible length, and (3) obtain FDA clearance on the tools allowing them to be routinely used in direct patient care. The resulting product would dramatically improve the information that neuroradiologists have access to for patient diagnosis, staging, and the assessment of the efficacy of therapeutic interventions for disorders including AD, tumor, hydrocephalus, and epilepsy, to name a few.

Public health relevance
PUBLIC HEALTH RELEVANCE: The technology that is currently routinely available to neuroradiologists is years or decades behind that which is used in imaging research throughout the world. In this proposal we seek to bridge the gap between research and the clinic, by developing a clinical utility based on FreeSurfer, the world's leading software package for automated brain morphometry. The result will be a tool that dramatically increases the accuracy, sensitivity and robustness of clinicians' abilities to diagnose, stage and assess treatment efficacy in a wide array of neurologic conditions such as Alzheimer's disease, tumor and hydrocephalus, to name a few.